RNA SPLICING CONTROL IN ROUS SARCOMA VIRUS

DESCRIPTION (Adapted from Abstract): This application uses the Rous sarcoma virus (RSV) as a model to study regulation of RNA processing. RSV primary transcripts are spliced by the host RNA splicing machinery, but this process is controlled since the majority (75%) of the RNA remain unspliced to serve as the message for the gag-pol proteins and as genomic RNA for progeny virions. Viral proteins are not required for the normal processing indicating that the cis elements are in the RNA and host-derived trans-acting factors are responsible for the ratio of spliced to unspliced RNA. This study characterizes these cis and trans-acting factors. One control element has been identified, the Negative regulator of splicing (NRS), which is located in gag and is distinctive in that it is not located near any of the splice sites, yet suppresses both the env and src 3 splice sites (ss). Two subregions of the NRS have been identified; an upstream purine-rich region that binds essential splicing factors called SR proteins and an unknown factor (p55), and a downstream sequence that is required for binding of U11 snRNP, an RNP particle that recognizes the 5 ss in a new class of rare introns (AT-AC introns). U1 and U2, abundant snRNPs of the major splicing pathway also interact with the NRS RNA. Four specific aims are proposed. The first uses in vivo and in vitro approaches to further characterize the cis elements and trans-acting factors which govern NRS splicing inhibition. The second aim tests a hypothesis that the U11 snRNP, when bound to the NRS interacts nonproductively with the major pathway splicing factors present at the authentic 3 ss, excluding pairing with the authentic 5 ss. The third aim studies an element which suppresses src splicing, named the SSS. The final aim investigates the basis of the position dependence of the NRS and SSS in splicing inhibition. This may be effected by splice site competition or the position relative to the 5' cap structure.